Cholesterol Homeostasis in the Retina

Cholesterol is abundant in the retina, which maintains cholesterol homeostasis by balancing the pathways of
cholesterol input and output. Retinal cholesterol input includes local biosynthesis and uptake from the systemic
circulation. Retinal cholesterol output is realized via photoreceptor phagocytosis, metabolism to oxysterols by
cytochrome P450 enzymes, and transport to the systemic circulation by lipoproteins. Elaborate mechanisms
control and coordinate retinal cholesterol input and output to maintain lipid steady-state levels. Accumulating
data implicate retinal cholesterol dyshomeostasis in the pathogenesis of age-related macular degeneration
(AMD), the leading cause of vision loss in the elderly of the industrialized world. The details of the cholesterol-
AMD link are, however, still unclear, due to insufficient knowledge about retinal cholesterol maintenance. During
the previous grant period, we ascertained: 1) the relative contributions of retinal cholesterol biosynthesis and
uptake of systemic cholesterol to the total retinal cholesterol input; 2) retinal significance of cholesterol transport
and storage; and 3) the effect of different pharmacologic treatments on lowering retinal cholesterol. Specifically,
we found that local biosynthesis is the major source of retinal cholesterol in mice, and a pathway, which can be
inhibited by a cholesterol lowering drug simvastatin. Furthermore, we established that apolipoproteins E and D
are important for retinal cholesterol transport, a pathway which could be targeted pharmacologically as well and
lead to retinal cholesterol lowering. Finally, we discovered that cholesterol excess could be esterified in the retina
and form lipid droplets, i.e., identified a mechanism for managing retinal cholesterol overload. In this renewal we
will continue to delineate the unknown aspects of retinal cholesterol maintenance that are of unquestionable
importance for our understanding of how to combat AMD. Aim 1 will evaluate hamsters as a model for studies
of retinal cholesterol. Among rodents, hamsters are much closer to humans than mice in terms of their whole
body cholesterol maintenance. Hence, we will investigate whether there is any advantage in using hamsters for
establishing the details of retinal cholesterol homeostasis as well as pharmacologic treatments. Aims 2 and 3
will still use mice as studies under these Aims should not be affected by potential interspecies differences in
retinal cholesterol maintenance. Aim 2 will focus on 2-hydroxypropyl-b-cyclodextrin, the FDA-approved
pharmaceutical that targets cholesterol distribution. The pharmacologic potential of this cholesterol-related
process for retinal cholesterol lowering has not yet been investigated and will be tested on several mouse
models. Aim 3 will establish retinal significance of apolipoprotein J for the pathway of retinal cholesterol
transport. Several apolipoproteins appear to be necessary for cholesterol trafficking in the retina, including
apolipoprotein J, a protein with unique functions. Collectively, the three Aims will provide principally new
information about cholesterol in the retina and facilitate the development of new therapeutics for the diseases
associated with deleterious accumulations of cholesterol in the retina and Bruch’s membrane.

Public health relevance
This research will advance our understanding of how cholesterol is handled in the retina and may facilitate the development of pharmacologic treatments for such eye diseases as age-related macular degeneration.